Novel Roles of Cullin-RING E3 Ligases in Liver Pathophysiology

Project Summary
NAFLD is closely associated with obesity and type-2 diabetes. Both improved understanding of the disease
pathophysiology and discovery of novel therapeutic targets for NAFLD treatment are urgently needed. Cullin-
RING E3 ligases (CRLs) are a unique sub-class of ubiquitin ligases that are activated upon neddylation of the
cullin scaffold. Mammalian cells contain functionally distinct CRL complexes that recognize specific protein
substrates for ubiquitination and subsequent proteasomal degradation. CRLs are considered promising drug
targets due to their regulation of disease relevant cellular pathways, higher substrate selectivity and lack of
broad cellular impact upon inhibition. Recently, CRLs have emerged as novel regulators of nutrient signaling
and inflammatory response in different organ systems. However, the roles of hepatic CRLs in NAFLD
pathophysiology is still largely unknown. The goals of this project are to delineate the functional impact and
underlying mechanisms by which CRLs regulate hepatic lipid and glucose metabolism and to establish CRLs
as valid therapeutic targets for developing NAFLD and diabetes treatment. This project is developed based on
our key findings that hepatic CRLs are abnormally activated in human NASH livers and murine NAFLD, and
pharmacological inhibition of hepatic CRL activity by targeting cullin neddylation improved insulin sensitivity,
reduced hyperglycemia and liver steatosis by countering the abnormally elevated gluconeogenic and lipogenic
activity that drives NAFLD progression. We will perform mechanistic studies to establish a working model
whereby pharmacological CRL inhibition prevents abnormal liver insulin receptor substrate degradation, the
key underlying cause of hepatic insulin resistance in NAFLD, and attenuates ChREBP-driven de novo
lipogenesis, therefore simultaneously achieves glucose and lipid-lowering effects. Specific aims are designed
to dissect the specific downstream CRL complex that mediates the beneficial effects of cullin neddylation
inhibitors and to identify and functionally validate the CRL substrate receptors that can serve as new
therapeutic targets for future drug development. This study employs new tissue-specific genetic knockout mice,
AAV8-mediated liver-specific gene delivery, and pharmacological treatment models. These models will be
investigated with a combination of molecular and cell biology techniques, metabolic phenotyping,
hyperinsulinemic-euglycemic clamp, and unbiased transcriptomics and proteomics approaches. By employing
these state-of-the-art models and techniques, our working hypothesis can be rigorously tested and new
mechanistic insights will be obtained.

Public health relevance
Project Narrative Fatty liver disease is closely associated with obesity and type-2 diabetes but without available effective drug therapies. This study investigates the mechanisms of Cullin-RING E3 ligases regulation of hepatic nutrient signaling and glucose and lipid metabolism in mouse models of obesity and fatty liver disease. In addition, this study will use pharmacological approaches to study if Cullin-RING E3 ligases can serve as potential therapeutic targets for treating lipid and glucose dysregulation in fatty liver disease and type-2 diabetes.